California Department of Food and Agriculture AFRPS Maintenance and PC Option

Project Summary/Abstract
The California Department of Food and Agriculture (CDFA) works to ensure the safety
of the food and feed supply through effective prevention, intervention, and response
programs. Within CDFA, the Commercial Feed Regulatory Program (CFRP) is
responsible for the enforcement of California state law and regulations pertaining to the
manufacturing, distribution and labeling of commercial livestock feed while preventing
adulterated feed from being consumed by livestock.
The goal of the proposed project is to maintain and enhance California’s fully
implemented Animal Feed Regulatory Program Standards (AFRPS) while building
CFRP’s ability to perform regulatory work and promote compliance with the Preventive
Controls for Animal Food (PCAF) rule. Through active participation in the AFRPS,
CFRP has strengthened its already robust inspection and enforcement programs,
industry education and training programs, and feed emergency response programs,
while also implementing program assessment and accountability measures. This
cooperative agreement would enable CFRP to further develop and sustain the best
practices implemented under the AFRPS while simultaneously working to build capacity
to conduct comprehensive inspections for compliance with the PCAF rule.
CFRP is seeking $525,000 annually for the next five years; this includes $225,000 for
maintenance and enhancement of the AFRPS, plus $300,000 to support incorporation
of CGMP and PC animal food inspections. Funds will be used to support one dedicated
staff member to continue further development and maintenance of the AFRPS, plus an
additional staff member to oversee implementation of the preventive controls funding
option. These funds will supplement existing capabilities and will enable CFRP to further
enhance its animal feed regulatory program through additional training and
development of staff, enhanced information sharing and interagency collaboration, and
expanded program evaluation. Ultimately this will allow the program to build a
foundation that will support sustaining full conformance with AFRPS and PCAF
compliance beyond this grant period. This will increase CFRP’s ability to conduct high-
quality comprehensive inspections and investigations to reduce the incidence of animal
feed contamination and, ultimately, foodborne illness associated with animal products.

Public health relevance
Project Narrative The goal of the proposed project is to support the California Department of Food and Agriculture (CDFA) Commercial Feed Regulatory Program (CFRP) in maintaining and enhancing its full implementation of the Animal Feed Regulatory Program Standards (AFRPS) while building the program’s ability to perform regulatory work and promote compliance with the Preventive Controls for Animal Food (PCAF) rule. In addition to maintaining full conformance, the CFRP will augment and update existing AFRPS procedures to ensure full support of Preventive Controls of Animal Food work through continued extensive collaboration, cooperation, and coordination with the U.S. Food and Drug Administration, other national, state and local agencies, and industry. These activities will further enhance CFRP’s ability to prevent, intervene, and respond to animal feed emergencies while better aligning state activities with a national integrated animal feed safety system, thereby achieving the overall goal of protecting public health by assuring food and feed commodities are safe for commerce.